Mentorship in Biobehavioral Mechanisms of Avoidant/Restrictive Food Intake Disorder

PROJECT SUMMARY/ABSTRACT
The applicant, Jennifer J. Thomas, Ph.D., is the Co-Director of the Eating Disorders Clinical and Research
Program at Massachusetts General Hospital and Associate Professor of Psychiatry at Harvard Medical School.
Over the last decade Dr. Thomas’s research has focused on the pathophysiology and treatment of feeding and
eating disorders, particularly the newly recognized avoidant/restrictive food intake disorder (ARFID). Her
successful mentoring experience, publication record, and current funding demonstrate her commitment and
passion for patient-oriented research and provide an excellent foundation to accomplish the goals and objectives
of the proposed K24 Award. Dr. Thomas’s career development goals will enable her to (1) deepen her expertise
in multimodal neuroimaging techniques (integrating structural, functional, and diffusion MRI) to enhance her
multidisciplinary collaborations and ability to provide translational mentorship; (2) create a sustainable
infrastructure for continued research mentorship of diverse scholars to develop their own unique expertise within
ARFID that will extend beyond her laboratory and beyond the K24 period; and (3) bring together her two lines of
research (on behavioral treatment of ARFID and neurobiology of ARFID) to develop new treatments that modify
target neural mechanisms using advanced clinical trial designs. The proposed award will enable Dr. Thomas to
redistribute her effort to 30% mentorship; 60% research; and 10% patient care. Dr. Thomas will further establish
a patient-oriented research program that uses innovative multidisciplinary techniques to investigate the
neurobiology underlying avoidant and restrictive eating, and that provides an ideal environment to develop future
leaders in clinical research across disciplines. The training environment is outstanding in terms of didactic
resources and availability of techniques to assess cross-disciplinary endpoints. Importantly, Dr. Thomas has a
strong commitment from Psychology and Psychiatry leadership, and a cadre of multidisciplinary collaborators
and senior advisors, who have enthusiastically endorsed her research program, mentoring, and K24 proposal.
The specific research aims of the application are based on a recently funded R01 investigating the link between
hormones, brain function and clinical features in adults with ARFID. Important new directions under the auspices
of this award will feature multimodal neuroimaging, including assessment of brain structure (gray matter volume
and white matter connectivity) and its relationship with functional brain abnormalities and clinical features. In the
long-term, this K24 award will build capacity in the next generation of scholars to advance research in
biobehavioral mechanisms of feeding and eating disorders.

Public health relevance
PROJECT NARRATIVE Avoidant/restrictive food intake disorder (ARFID) is a serious and impairing feeding and eating disorder that affects 1-3% of children and 1-4% of adults, resulting in weight loss, nutritional deficiencies, dependence on nutritional supplements, and/or psychosocial impairment. The PI, Dr. Jennifer Thomas, is an expert in patient- oriented research in feeding and eating disorders and has a strong commitment to mentorship of junior colleagues. This K24 award will enable her to grow her skills in multimodal neuroimaging, establish a new line of research to identify structural brain abnormalities that may contribute to ARFID etiology or maintenance, and create a sustainable infrastructure for continued research mentorship of diverse scholars across disciplines and institutions with the goal to develop them into independent clinical researchers who can successfully fulfil the NIMH strategic plan.